Ex Vivo Imaging of the Aging Brain to Discover Morphology/Pathology Associations

Alzheimer's disease (AD) is associated with surprisingly high degree of pathologic heterogeneity. In most
individuals diagnosed with AD at autopsy, the brain not only harbors the β-amyloid and tau pathologies that are
the hallmarks of AD, but also one or more co-pathologies, including TDP-43, α-synuclein, non-AD tauopathy,
and cerebral small vessel disease (SVD). The primary AD pathologies and co-pathologies all contribute to
neurodegeneration in AD, but their relative contribution in different brain regions and the degree in which co-
pathologies modulate the progression of primary pathologies is not well understood. It is widely recognized that
it is important for clinical trials in AD to account for these additional drivers of neurodegeneration, but there is a
lack of in vivo biomarkers that can reliably detect and quantify co-pathology. Pathologic heterogeneity may help
explain why AD treatments targeting a single pathological mechanism have been largely ineffective.
This project seeks to address this limitation by using ex vivo human brain MRI to characterize the contributions
of primary AD pathologies and co-pathologies to neuronal loss and cortical thinning in AD. The project leverages
a prospective dataset from 100-120 autopsies conducted at the University of Pennsylvania AD Research Center
that will include high-resolution 7 Tesla MRI of intact brain hemispheres with co-registered histology at selected
gray matter locations and around white matter lesions. Moreover, the temporal lobe, part of the brain where
earliest and most severe AD-related neurodegeneration occurs, will be scanned at 9.4 Tesla, and undergo serial
histological imaging, allowing three-dimensional mapping of tau pathology (tangles, threads, etc.) and neuronal
density across the entire temporal lobe. This unique ex vivo imaging dataset will represent a convergence of
structural and pathological imaging data in the same 3D space, allowing a broad range of studies analyzing
trajectories of pathology deposition and pathology-neurodegeneration relationships. The specific aims of the
proposal are as follows. Aim 1 is to develop deep learning-based image analysis techniques for 7 Tesla whole-
hemisphere MRI, which are currently lacking, including segmentation of cortical gray matter, white matter lesions,
normal-appearing white matter, and subcortical structures; groupwise registration to both ex vivo and in vivo MRI
templates; and extraction of both MRI-based and histological features to characterize white matter lesions
associated with SVD. Aim 2 is to analyze the complete 100-120 specimen dataset to characterize the distribution
of tau pathology, neuronal loss, and cortical thinning both in the temporal lobe and in the whole brain and to
describe the impact of co-pathologies on these distributions and on the relationships between them. Aim 3 is to
leverage pathology-specific “signatures” extracted from analyzing this ex vivo dataset to improve the sensitivity
of in vivo biomarkers for inferring the presence of co-pathology and tracking disease progression.

Public health relevance
In Alzheimer's disease (AD), cognitive impairment is caused by the damage to neurons and other brain cells, but this damage has many causes, including cardiovascular disease and molecular abnormalities that are linked to other kinds of dementia. Understanding how different molecular abnormalities and cardiovascular disease contribute to neuronal damage in AD can make clinical trials more effective, for example by only including individuals whose brain changes are caused by factors related that the experimental treatment is meant to address. This project will use postmortem imaging of human brains to better describe how cardiovascular disease and different molecular abnormalities contribute to neurons damage and to develop tools for clinical trials to account for these factors.